Novel Therapeutics for Timothy Syndrome and Related Cardiac Channelopathy

Project Summary:
Calcium channel dysfunction in heart muscle cells induces cardiac arrhythmias such as Timothy syndrome, a
severe form of genetic long QT syndrome type 8. In preliminary experiments using pharmaceutical approach,
we found that activation of Sigma 1 receptor using its agonists could alleviate the cellular phenotypes in human
induced pluripotent stem cell (iPSC) and mouse models of the genetic disease. The goal of this study is to design,
synthesize and characterize new small molecules to develop novel Sigma 1 receptor agonists that are more
suitable for the cardiac phenotypes in the genetic disease. To accomplish this goal, we will take advantage of
our experience and expertise in pharmaceutical science and medicinal chemistry using human iPSC and rodent
models to address our hypotheses. In addition, we will examine whether our approach using the new small
molecules can be applicable for common forms of genetic long QT syndrome such as type 1 and 2. Therefore,
our translational study will provide new opportunity of drug development for genetic cardiac arrhythmias.

Public health relevance
Project Narrative: This project will investigate the molecular mechanism underlying a genetic syndromic disorder called Timothy syndrome showing severe and lethal cardiac arrhythmia. Our team will take advantage of our new technology and expertise to develop new drug candidates on experimental platforms using cardiac muscle cells derived from human patients as well as small animal models. This translational approach will open new avenue to identify novel therapeutics for human genetic cardiac arrhythmias.